Development of Automated Motility and Strabismus Evaluation for diagnosis and treatment

305,509 veterans received a new diagnosis of strabismus (misalignment of the two eyes) between
2010 and 2021, and many of them have double vision (diplopia). Diplopia decreases the quality of vision and
leads to the inability to perform tasks of daily living (like working, reading, and driving) with significant disability.
Strabismus is a visible physical deformity that impairs the ability to make eye contact and affects self-esteem,
mental health, employability, and overall quality of life. Eye- movement abnormalities and strabismus are
sometimes associated with systemic or neurologic diseases.
Diagnosis and treatment of eye movement abnormalities and strabismus rely on accurately determining
the pattern and degrees of misalignment in different gaze positions and analyzing the accuracy of monocular
and binocular eye movements. A team of professionals, including adult strabismus surgeons, orthoptists, and
neuro-ophthalmologists, is involved in the labor and time-intensive process of obtaining this information.
Treatment recommendations are broad, including placement of prisms in glasses, patching, surgery, imaging,
labs, medication, or a combination. Immediate rehabilitation of quality of vision can be obtained by placing
prisms in patient's glasses. A significant barrier to the care of veterans affected by strabismus is the lack of
trained personnel (in and outside the VA system) to determine the magnitude, direction, and patterns of eye
misalignment and eye movement abnormalities, leading to long wait times for an appointment. Thus, care and
visual rehabilitation is frequently delayed for months.
Eye-tracking technology that can be used to record eye movement abnormalities is commercially
available. Still, a critical need exists for algorithms that can analyze this information to assist in patients'
diagnosis, treatment, and workup. In this project, we aim to optimize current eye-tracking protocols and
software to determine ocular misalignment, patterns of strabismus, and the dynamics of eye movements from
the recordings. We will also employ machine learning computational techniques to uncover diagnostic
characteristics from the eye movement recordings. The innovation of this proposal is to automate the eye
movement and misalignment evaluation as well as the clinical interpretation and thereby reduce or eliminate
the involvement of strabismus experts and neuro-opthalmologists. To validate the algorithms, we will compare
them with the current standard of care - evaluation of sensorimotor manual measurements by experts.
The availability of fast, reliable, and affordable assessments of eye motility and strabismus in every
ophthalmology clinic in the VA Health Care system will make evaluation readily available and overcome current
limitations. Treatment and workup recommendations will be immediately available, allowing veterans to be
treated using existing technology and current personnel.
The proposed study is the first and largest to use eye-tracking recordings to develop algorithms and
software to classify eye misalignment and motility patterns, which will then be used to generate accurate
treatment plans. At the Iowa City VA ophthalmology clinic and Center for the Prevention and Treatment of
Visual Loss, we are uniquely positioned for success in this project by having an expert team of an adult
strabismus specialist/surgeon, an orthoptist, and a neuro-ophthalmologist to perform manual measurements,
accurate diagnosis, and treatment for these conditions.
If successful, this system will assist healthcare professionals in detecting, diagnosing, and planning
personalized treatment for strabismus patients, ultimately leading to improved outcomes and quality of care.
Further, it will result in increased access to health care and faster treatment for Veterans, higher productivity
for eye care providers, and reduced fee-based costs to the VA Health Care system for non-surgical cases. The
veterans' ability to function independently and overall quality of life, self-esteem, and employability will improve.

Public health relevance
Eye misalignment affected the quality of vision for 305,509 veterans between 2000 and 2021. Lack of timely access to highly specialized medical personnel delays the medical care for veterans with eye-movement abnormalities and double vision. In this project, we propose using eye-tracking technology and machine learning to automatically measure and analyze the magnitude and patterns of eye misalignment and movement abnormalities to assist in the diagnosis, treatment, and workup of veterans affected by strabismus. If successful, the method will overcome the lack of specialized personnel able to obtain these measurements in the VA Health Care system and enable the evaluation to be performed in any ophthalmology clinic, with the current personnel, at the time of patient visit. In many cases, immediate visual rehabilitation will be possible by placing prisms in the patient's eyeglasses, improving their ability to function independently and overall quality of life. Evaluation without delay will increase access to health care and higher satisfaction for Veterans.